Community Liaison and Recruitment Core-MCUAAAR

Community Liaison and Recruitment Core Abstract
African American older adults continue to lag dramatically behind Non-Hispanic Whites in terms
of both health outcomes and participation in health research. The most common barriers to
research recruitment are fear and mistrust. The Healthier Black Elders (HBE) Participant
Registry of the MCUAAAR employs best practices in the science of recruitment, retention, and
continuing program evaluation. We propose two major ways we will initially extend the
MCUAAAR's work in recruitment, retention science, and community translation. First, we will
conduct a long-term retention study on the MCUAAAR Registry, including a recruitment and
retention study of participants in the University of Michigan Alzheimer's Disease Center's
(MADC) longitudinal study of memory and aging. Second, we will broaden our reach through the
expanded institutional MCUAAAR partnership with Michigan State University (MSU), and
continuing collaborations with the MADC, and the Wayne State University (WSU) Environmental
Health Center, among other NIA/NIH Centers in the new Internal Resources Group; and, use
the logic model to extend immediately the MCUAAAR Registry into the Flint community and
engage with community dwelling African American older adults. Our three specific aims for the
CLRC include: 1) Contribute to the science of recruitment and retention of older African
Americans by further testing the efficacy and efficiency of the Participant Registry; 2) Extend
and expand partnerships with community-based organizations in Detroit and Flint; and, 3)
Disseminate to, and translate scientific information for, the respective communities. The CLRC
is clearly present in all of the MCUAAAR core activities. In the Administrative Core, the Healthier
Black Elders Center is housed within the WSU of Gerontology, which is led by MCUAAAR Co-
Director Peter Lichtenberg. The REC will oversee specific educational opportunities in
community-based research and research partnerships, both among the faculty and junior
research investigators at the three universities year-around, and in the long-running summer
workshop program. The Analysis core will assist in recruitment and retention research by
applying the best measures, methods, and statistical design and analyses to the long-term
retention study.